Mode of Ventilation During Critical Illness at Multiple Centers: a Pragmatic Clinical Trial

PROJECT SUMMARY
Candidate: Kevin P. Seitz MD, MSc is an Instructor in Medicine and, by the time of this award, will be an
Assistant Professor in the Division of Allergy, Pulmonary, and Critical Care Medicine at Vanderbilt. Dr. Seitz
has a strong background in randomized trials among critically ill adults. His long-term plan is to be an
independent physician-scientist and a leader in randomized trials of complex interventions in the ICU. During
this career development award, he will lead a multicenter trial and develop the expertise in implementation
science needed to optimize adherence during pragmatic trials of complex interventions in the ICU.
Research Project: Every year, millions of adults in the United States receive invasive mechanical ventilation
in ICUs, with a high risk of mortality. When using a mechanical ventilator, clinicians must choose from
ventilator modes that control the tidal volume (volume control), the inspiratory pressure (pressure control), or a
dual-control of volume and pressure using adaptive algorithms (adaptive pressure control). Data to inform the
choice of mode are limited, and arbitrary variation in current practice may be harming patients. A multi-center
trial is needed to understand the effects of ventilator mode on clinical outcomes. A pragmatic trial embedded in
clinical care is appropriate for this goal. Ventilator mode use is a complex, multi-disciplinary, longitudinal
intervention. Implementation science provides tools to identify and mitigate barriers to adherence for complex
interventions in clinical care across varied settings that are well-suited to optimizing adherence to the assigned
ventilator mode in a pragmatic trial. The Specific Aims of the proposed research are: Aim 1) Conduct the Mode
Of ventilation During critical illnEss at Multiple centers (MODEM) trial, a 4,785-patient randomized cluster-
crossover trial of critically ill adults testing the hypothesis that adaptive pressure control will increase the
number of days alive and free of mechanical ventilation compared with volume control or pressure control. And
Aim 2) Apply mixed methods to identify and intervene upon contextual factors that affect the adherence to the
treatment group assignment in the MODEM trial, testing the hypothesis that this approach will result in at least
90% fidelity to assigned treatment in a pragmatic, multicenter trial of a complex intervention.
Career Development: Dr. Seitz’s plan integrates coursework, experiential learning, and training with mentors
to: 1) become expert in designing and leading comparative effectiveness trials embedded in clinical ICU care,
2) develop expertise in implementation science methods and proficiency in qualitative methods to improve the
conduct of pragmatic trials, and 3) develop leadership skills to lead large, multi-center clinical trials.
Environment: As a supportive and well-resourced institution with international leaders in clinical trials, critical
care, human subjects protection, implementation science, bioinformatics, and biostatistics, Vanderbilt is the
ideal environment to foster Dr. Seitz’s development into a national leader in trials of complex interventions.

Public health relevance
PROJECT NARRATIVE Millions of critically ill adults receive invasive mechanical ventilation in an intensive care unit each year, of whom 25-35% die in the hospital, but the optimal ventilator mode, a setting that determines how a ventilator delivers breaths to the patient, is unknown. We designed the Mode of Ventilation During Critical Illness at Multiple Centers (MODEM) trial to determine which mode (volume control, pressure control, or adaptive pressure control) results in the greatest number of days alive and free of mechanical ventilation for critically ill adults. We will optimize adherence to the assigned ventilator mode in the MODEM trial using implementation science frameworks and tools for the delivery of complex interventions in clinical care.